E-cigarettes and oral wound healing: an integrated omics approach

Project Abstract
Impaired wound healing is both a financial and medical burden for patients. In the oral cavity, early and complete
wound closure is a critical determinant of the success of surgical treatments ranging from extractions to grafting.
Oral health is mediated by a diverse microbial ecosystem, and there is evidence that dysbiosis in this microbiome
can contribute to poor wound healing outcomes. Wound healing outcomes can be influenced by a wide range of
factors, one of which might be e-cigarettes, also referred to as electronic nicotine delivery systems (ENDS).
These devices deliver an aerosol mixture by heating propylene glycol, glycerol, nicotine, additives and flavorings.
Although concerns have been voiced about these devices, usage continues to increase, partially as a result of
being marketed as a safer alternative to traditional cigarettes and as a smoking cessation aid. However, evidence
is emerging to suggest that ENDS negatively impact wound healing outcomes. These results combined with an
increase in usage emphasize that there is an urgent need to investigate the biological effects of ENDS. Our
preliminary data has shown that ENDS exposure increases the virulence potential of the oral microbiome and
elicits a brisk proinflammatory response in ENDS users. Therefore, we hypothesize that ENDS promote the
growth of anaerobic bacteria in the oral cavity, prolonging post-surgical inflammation and resulting in delayed
oral wound healing and time to wound closure. We propose to test this hypothesis by combining an integrated
‘omics’ approach with a clinical study design and validate this with an in vitro model that recapitulates oral wound
healing events. This approach will measure the clinical effects of ENDS use on oral wound healing, as well as
identify the mechanisms behind these clinical events. In Aim 1, we will quantify the clinical impacts of ENDS on
oral wound healing using a longitudinal case-control intervention study. Biopsy samples will be utilized for host
transcriptomics, metatranscriptomics and metabolomics and the time to wound closure will be measured. In Aim
2, we will validate these results using an in vitro model of cutaneous wound healing and explore the mechanisms
by which ENDS impact wound healing events. Since successful wound healing relies on oral microbial
homeostasis, we will combine host epithelium with an underlying fibroblast layer and construct of core microbes.
Host transcriptomics, metatranscriptomics and metabolomics will be analyzed and validated with RT-qPCR. By
combining the complexity of a clinical model with a highly controlled in vitro experiment, the proposed study will
provide important evidence to understand the role of ENDS in disrupting host microbial homeostasis, provide
new understanding of the complexities of ENDS on oral wound healing and establish indicators of ENDS
associated host microbial dysbiosis.

Public health relevance
Project Narrative Non-healing wounds present a major impediment to health outcomes, yet preliminarily data has shown that e- cigarettes negatively impact wound healing outcomes. The proposed studies will use an interactive “omics” approach to elucidate the complex interactions that occur in the oral cavity with e-cigarette use. Understanding the effect of e-cigarettes on the oral host-bacterial response during wound healing events will provide the necessary evidence for public health policy and dental healthcare providers to advise on the usage of these devices.